SOMATROPIN ADMINISTERED DAILY TO PATIENTS WITH GROWTH HORMONE DEFICIENCY

Children in this study are being treated with recombinant DNA growth hormone on a daily basis. The rate of growth in these children, as compared to children who have received growth hormone on an every other day basis, will be compared.